Regulation of FGF signaling in lacrimal gland development

PROJECT SUMMARY
The long term objective of this project is to investigate regulation of FGF signaling in lacrimal gland
development, which has important implications for understanding the etiology of diseased lacrimal gland in
human. The lacrimal gland develops through a branching morphogenesis process primarily driven by FGF.
We have previously shown that the Ras-MAPK pathway is an important downstream target of FGF signaling in
lacrimal gland morphogenesis. In this application, we will test the hypothesis that PLCγ is also a critical
regulator of FGF signaling in lacrimal gland development. Using conditional mutant mice and cell culture
models, we will study how FGF receptor recruits and activates PLCγ. We will also examine the crosstalk
between PLCγ and Ras signaling in lacrimal gland development. Finally, we will test the hypothesis that PLCγ
modulates the strength of FGF signaling by controlling endocytosis of FGF receptor. By investigating the
regulation of FGF signaling in murine lacrimal gland, this project will contribute to medical research in treating
human lacrimal gland deficiency and the dry eye disease.

Public health relevance
PROJECT NARRATIVE This project investigates the mechanism of FGF signaling in lacrimal gland development. It is expected to contribute to our understanding of this important pathway in human development and disease, and inform future development of clinical interventions to treat the dry eye disease.